Research Training in Otolaryngology

Our program aims to train and develop physician-scientists who will advance the field of
otolaryngology-head and neck surgery. Our subspecialty requires a wide variety of expertise
and scientific strategies for understanding and treating communication disorders and diseases
of the head and neck. These diseases can limit survival, and more broadly affect the ability to
relate to family, workplace and society at large. We aim to provide the scientific training, as well
as communication and administrative skills that will enable our graduates to become creative
contributors to the future of otolaryngology and the treatment of associated communication
disorders. One significant indicator of success, and a point of great pride, is the number of
trainees who have gone on to academic careers at Hopkins and elsewhere, including several
who are now among the faculty of this training grant.
Two residents per year enter into 2 years of research training in their third year of
residency. These trainees can choose from a wide, and deep, selection of research programs
both within the department, and in associated laboratories at Hopkins and elsewhere. The
topics include, but are not limited to: basic mechanisms of, and therapeutic innovation for
dizziness and balance; studies of the auditory nervous system; pathogenesis of sinusitis,
laryngotracheal stenosis and respiratory papillomatosis; molecular biology and epidemiology of
head and neck cancers; surgical robotics; and public health studies in otolaryngology-head and
neck surgery.
We aim to educate enthusiastic, inquisitive, critical, and knowledgeable young
investigators who can pose and then answer significant questions and who will be able to
conduct successful, independent research careers in academic medicine.

Public health relevance
This is a training grant proposal to support 2 years of research for 2 trainees in the Oto-HNS residency. These trainees spend full-time learning and carrying out scientific research in the laboratory of participating faculty, with a view to becoming independent clinician-scientists.